NATIONAL CHILDHOOD CANCER REGISTRY (NCCR) DATA PLATFORM

The purpose: This project will support the NCI in planning, acquiring, developing, documenting, implementing, updating, and supporting childhood cancer research by applying commercially available information technology (IT) solutions in an NCI-approved environment. The contract and resulting IT and applications will assist researchers and the NCI to meet data sharing and scientific objectives in surveillance and public health analysis and cancer research, with an ultimate goal of improving treatments, quality of life, and survivorship of every child with cancer.